Training Program in Organogenesis

[unreadable] DESCRIPTION (provided by applicant): A Training Program in Organogenesis is being submitted by the Cincinnati Children's Hospital Research Foundation (CCHRF). The program will provide training in organ morphogenesis, dysmorphogenesis, and repair, and is a major focus of research in many different divisions at the CCHRF. This program aims to unify training in organogenesis by bringing together both clinical and basic science faculty and trainees with primary interests in this research discipline. Thirty-five faculty from nine divisions will form the core of mentors in the program. These comprise a mix of clinicians and basic scientists with primary interests in organogenesis. Faculty in the CCHRF hold primary appointments in the departments of Pediatrics (the majority), Surgery, Radiology, and Anesthesiology. In 2004 and the first few months of 2005, this group of training faculty has more than 180 publications, including papers in Nature, Cell, Science, Nature Immunology, Nature Cell Biology, Nature Medicine, Molecular Cell, The Lancet, PNAS, and Development, as well as other premier specialist journals. Trainees in this program will be graduate students, postdoctoral fellows, and clinical fellows in training at CCHRF. Graduate students from three programs in the University (M.D./Ph.D., Molecular and Developmental Biology, and Neurosciences) carry out their training in laboratories in the CCHRF. There are currently 81 postdoctoral fellows in basic science laboratories, and 152 clinical fellows. CCHRF has made a major investment in basic research in recent years, by recruiting new faculty in divisions of Developmental Biology, Pulmonary Biology, Molecular Cardiovascular Biology, Immunology, and Experimental Hematology. The program will dramatically enhance and unify one of the major foci of research at CCHRF, and establish new leaders in this field, at a time when insights into the basic mechanisms of organogenesis can make a real impact on the understanding, diagnosis, and treatment of congenital disorders of organ formation in children. [unreadable] [unreadable] [unreadable]